Building Interdisciplinary Research Careers in Women's Health at UC Davis

PROJECT SUMMARY
For this administrative supplement to our K12 BIRCWH grant, UC Davis is requesting support
to add a fourth Scholar to our program for two years. We will train a Scholar of Vietnamese
descent whose background meets the NIH criteria for being from an underrepresented
minority group and disadvantaged background in interdisciplinary women’s health and sex
differences research. This proposed Scholar is within 6 years of a terminal degree and will engage
in interdisciplinary women’s health and/or sex/gender disparities, team science-based research and
create an independent development plan for her pathway to independence. Her research focus will
be cancer prevention in women through implementation science and will fit well into our
BIRCWH crosscutting themes: 1) a lifespan approach to understanding normal development,
illness/disease, and aging; 2) sex and gender determinants; 3) health disparities; and 4)
interdisciplinary research.
Over the past 17 years, the UC Davis BIRCWH program has trained a sizeable, diverse cadre of
interdisciplinary researchers in women’s health and sex differences and heightened the visibility and
prominence of this research. We will build on this strong foundation to create a next-generation
BIRCWH program, led by PI, Dr. Nancy Lane, that increases its innovation and impact. We aim to
foster an academically stimulating and nurturing environment for researchers in women’s health and
sex differences, to facilitate their career development and encourage paradigm-shifting,
interdisciplinary collaboration, and team science to advance research in women’s health and sex
disparities. Our short-term BIRCWH objectives are to: 1) provide in-depth, individualized training and
team-based interdisciplinary mentoring to support the independent career development of Scholars in
interdisciplinary women’s health and sex differences research; and 2) advance and achieve high-
impact women’s health and sex/gender differences research by establishing cross-disciplinary
collaborations with UC Davis schools that advance science and health. Our long-term objectives are
to: 1) improve women’s health by enhancing understanding of the unique aspects of female sex and
gender and translating this knowledge to clinical practice; 2) develop transformative interdisciplinary
team science for women’s health and sex/ gender disparities research; and 3) train leaders in
interdisciplinary women’s health and sex differences research.
To accomplish our objectives, our proposed new BIRCWH Scholar will participate in: 1) team-
based, interdisciplinary mentored research and career development activities; 2) core courses on
study design, grant writing, biostatistics, communication, team science and responsible conduct of
research; 3) supplemental courses tailored to each Scholars’ needs and interests; 4) team-based
interdisciplinary research; 5) integrated journal clubs; 6) monthly breakfast meetings with the PI and
RD to discuss research and career progress; 7) a biannual symposium of Northern California
BIRCWH programs; and 8) the School of Medicine (SOM) Mentoring Academy, for mentors and
Scholars to be trained in skills to optimize mentoring experiences. Our BIRCWH program will continue
to leverage campus expertise in four research areas: neuroscience/pediatric, neurodevelopment/
behavior, metabolic/inflammatory/nutrition-related syndromes, musculoskeletal diseases and aging
disorders, and cancer/opioid addiction to support this Scholar.

Public health relevance
PROJECT NARRATIVE In this administrative supplement to our UC Davis BIRCWH program (PI, Dr. Nancy Lane), we propose to build on the experience and achievements of our previous 17 years of the program to advance, promote, and achieve interdisciplinary training and mentoring of team-based science for the next generation of researchers in women’s health and sex differences. We are requesting to add a BIRCWH Scholar who is from an underrepresented minority group and disadvantaged background to our program for two years. We believe that our BIRCWH faculty, mentors, and this additional Scholar will work to improve the health of women and to improve our knowledge and understanding of the mechanisms and manifestations of sex differences in health and disease as well as of the unique afflictions women face with the ultimate goal of more effective prevention, diagnosis, and treatment.